Leveraging Digital Technologies to Advance Rehabilitation for Children with Unilateral Cerebral Palsy

Project Summary
Cerebral Palsy (CP) is the primary motor disability of childhood. Over half of all children with CP have upper
extremity (UE) deficits. Children with unilateral UE deficits benefit from intensive motor practice using the
weaker or affected arm while the dominant or unaffected arm is constrained in a splint or cast. This form of
therapy, pediatric constraint induced movement therapy (pCIMT), is one of the most effective treatments for
improving UE motor skills, but it is not available in many areas of the country. Telehealth may make pCIMT
accessible for families who live in rural areas, under-resourced settings, far away from pCIMT programs, or
those who face barriers to in-person visits (e.g., transportation). Early-stage pediatric research trials are
exploring telehealth interventions (mostly in infants and young children), but most still require in-person pre-
and post- assessments. For telehealth to truly reduce the health accessibility gap, scientists need to 1)
determine if telehealth pCIMT is effective in school-aged children, 2) compare telehealth and in-person UE
assessments, and 3) measure adherence to protocol dose for any parent-delivered components of treatment.
This proposal adds aims to a funded pilot efficacy trail (n=10) of intensive (60 hours in 4 weeks) telehealth
pCIMT study, CHAMP-T2, to address each of these needs. First, wrist-worn accelerometers will measure
changes in amount, magnitude, and symmetry of UE use. Accelerometers have been successful in measuring
change in UE movement and are highly correlated with functional measures. CHAMP-T2 participants and an
additional 25 subjects will be enrolled in a sub-study to compare the scores of in-person and telehealth
administrations of the Melbourne Assessment-2 and the Assisting Hand Assessment. If telehealth
administrations of these assessments have high agreement with in-person assessments, they may be suitable
for measuring change in future telehealth trials. Finally, because CHAMP-T2 depends on an on-site parent to
facilitate the child’s motor practice through a combination of video-conferencing sessions and at-home
practice, accelerometry watches will be used to quantify adherence to pCIMT treatment dose (e.g., frequency,
time, and type of intervention). If successful, this offers a low-burden alternative to activity logs or diaries for
monitoring adherence to dose during at-home practice. The applicant identifies training goals to advance
expertise in: 1) all phases of clinical trials, 2) remote collected UE assessment, 3) training parents in motor
intervention principles, and 4) stakeholder-led research. In addition, the applicant will complete lab rotations,
workshops, courses, and seminars to meet these training goals and enable the completion of the research
plan. The applicant is supported by an interdisciplinary team of mentors in pediatric rehabilitation (physical and
occupational therapy), engineering, and medicine, parent stakeholders, and a biostatistician.

Public health relevance
Project Narrative Telehealth motor intervention for children with unilateral cerebral palsy (UCP) has the potential to make effective therapies more accessible to families who live in rural or under-resourced areas, but we need to determine if telehealth therapies result in changes in upper extremity outcomes across the International Classification of Function. We will compare in person and telehealth activity-level outcomes and use wrist-worn accelerometers to measure changes in body structure/function in the real world and quantify the dose of intervention that parents deliver during at-home practice. Results will enable future trials to use digital technologies to collect motor outcome data and objectively measure adherence to at-home practice of UE activities.